The role of central CO2 chemosensitivity in postictal respiratory depression and SUDEP

Abstract
Sudden Unexpected Death in Epilepsy (SUDEP) occurs in up to 50% of patients with refractory epilepsy and is
the leading cause of death in this population. Because the mechanisms responsible for SUDEP have not been
clearly defined, there are no specific treatments to prevent it. Recent observations from human and animal
studies indicate that seizure-induced respiratory arrest typically precedes asystole, and that many patients
experience varying degrees of respiratory depression following seizures. There is a fundamental gap in
understanding how seizures depress respiration, and why some patients develop severe postictal respiratory
depression and others do not. Low central CO2 chemosensitivity can contribute to respiratory depression, and
it is possible that this predisposes to SUDEP, but has not been studied in this population. The long-term goal is
to develop new treatments to prevent SUDEP by elucidating the mechanisms responsible for seizure-induced
respiratory depression and by identifying biomarkers to identify patients at highest risk. The objective here is to
characterize the relationship between CO2 chemosensitivity and postictal respiratory depression by measuring
the slope of the hypercapnic ventilatory response (HCVR) in patients with epilepsy during the interictal and
postictal states. The central hypothesis is that postictal hypoventilation will be more severe in patients with low
interictal or postictal CO2 chemosensitivity. This hypothesis has been formulated based on human and animal
data obtained from the applicants’ own laboratories, data that also suggest serotonin (5-HT) defects may
contribute to SUDEP. Because 5-HT neurons are known to be important for normal CO2 chemosensitivity that
stimulates breathing and cortical arousal, the rationale for the proposed research is that defective chemo-
sensitivity might contribute to the pathophysiology of SUDEP. The central hypothesis will be tested by pursuing
3 specific aims. (1) Determine the relationship between baseline (interictal) central CO2 chemosensitivity and
postictal respiratory depression. (2) Determine how seizures affect central CO2 chemosensitivity. (3) Determine
the stability of the HCVR over time in patients with epilepsy, and the relationship of the HCVR to epilepsy
control. In Aims 1 and 2 patients admitted to the Epilepsy Monitoring Unit will undergo HCVR testing during the
interictal and postictal periods. The slope of the baseline HCVR will be correlated with ictal changes in CO2
levels and other cardiorespiratory variables (Aim 1), and the effect of different seizures on HCVR slope will be
measured (Aim 2). The intraindividual variability of the HCVR and its stability in relation to epilepsy control (Aim
3) will be determined by measuring the HCVR 4 times over 2 years. This approach is innovative because it is
the first to directly examine the relationship between postictal ventilation and central CO2 chemosensitivity in
the ictal and postictal states. The proposed research is significant because identifying the mechanisms
involved in postictal respiratory depression may lead to identification of a novel biomarker (HCVR) for SUDEP
risk and to development of new treatments designed to defend ventilation in the postictal period.

Public health relevance
Narrative Sudden unexpected death in epilepsy (SUDEP) is the leading cause of death in patients with refractory epilepsy. In many cases, death follows a period of severe seizure-induced respiratory depression, for which the cause is not understood. The proposed research is relevant to public health and the NIH’s mission because a better understanding of the role played by central CO2 chemosensation in the pathogenesis of seizure-induced respiratory depression is expected to lead to the identification of novel candidate biomarkers for SUDEP risk and to the development of new preventive treatments for SUDEP.